Connecting plasma membrane function to lipid structure and organization with asym

DESCRIPTION (provided by applicant): Over the past half century, as molecular biology and biochemistry have developed to inform our understanding of disease, and as this understanding has driven the search for treatments in biotechnology and molecular medicine, the dominant theoretical scaffold for interpreting molecular behavior has been the structure-function relationship. Our understanding of molecular biology's structure-function relationships is largely limited, however, to the molecules of the central dogma: proteins and oligonucleotides. The vast variety of molecular structure outside of the central dogma, particularly among lipids and carbohydrates, suggests that these, too, can be understood in terms of structure driving function. In particular, there has been intense interest in the functional role that lipids might play in the plasma membrane. This project deploys a new class of synthetic lipid bilayers to begin drawing connections between the structure of lipid molecules-both in terms of individual molecular structure and supermolecular organization-and the function of the plasma membrane. The research tools developed and deployed here, called asymmetric giant unilamellar vesicles (AGUVs), are designed to uniquely mimic the cell membrane, capturing properties such as compositional asymmetry and molecular crowding better than other existing synthetic lipid bilayers. One of the many questions that AGUVs can help answer involves passive transport across the cell membrane. Passive transport is an important route for drug delivery and passage of environmental toxins into cells. Recent results show that the mechanism of this transport is complex, and highly dependent on lipid behavior. This project deploys an AGUV-based technique for systematically measuring the dynamics of solute molecules interacting with and penetrating lipid bilayers, yielding richer mechanistic data than other approaches are capable of delivering. AGUVs can also be used to study the mechanical properties of the cell membrane. These properties- particularly resistance to bending-control protein function and are important in a range of physiological processes. While synthetic lipid bilayers have been used to probe these properties, little is known about the effects of bilayer asymmetry on them. This project uses AGUVs to discover these effects. Lipid interactions with integral membrane proteins are likely a major mode by which lipids influence cell behavior. Very little is known, however, about the origins or controlling parameters of these interactions. This project begins to untangle this problem in AGUVs by using fluorescence microscopy to probe how peptides modeling the transmembrane regions of various proteins associate with segregated lipid domains. Finally, AGUVs can facilitate the systematic study of the effects of macromolecular crowding in the cell interior. The microfluidic technique by which AGUVs are formed allows for the inclusion of arbitrary molecules within them, leading to unique molecularly crowded structures.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cells are surrounded by membranes that consist of two layers of lipid molecules, and the chemical composition is different in these two layers. In this project, a new type of artificial cell membrane that is uniquely capable of mimicking this asymmetry is deployed to study a range of important biological processes, including drug transport into cells, mechanical deformation of the cell membrane, and interactions between lipid molecules and receptor proteins involved in cancer treatment and diabetes. Cells are surrounded by membranes that consist of two layers of lipid molecules, and the chemical composition is different in these two layers. In this project, a new type of artificial cell membrane that is uniquely capable of mimicking this asymmetry is deployed to study a range of important biological processes, including drug transport into cells, mechanical deformation of the cell membrane, and interactions between lipid molecules and receptor proteins involved in cancer treatment and diabetes. __SpecificAimsTextDelimiter__ 1 Specific Aims Over the past half century, as molecular biology and biochemistry have developed to inform our understanding of disease, and as this understanding has driven the search for treatments in biotechnology and molecular medicine, the dominant theoretical scaffold for interpreting molecular behavior has been the structure-function relationship. Proteins take on complex three-dimensional molecular structures that determine their behavior. Nucleic acid structure facilitates replication, transcription, and translation, as well as the protein-DNA interactions that control gene expression. Our understanding of molecular biology's structure-function relationships is largely limited, however, to these molecules of the central dogma. The vast variety of molecular structure outside of the central dogma, particularly among lipids and carbohydrates, suggests that these, too, can be understood in terms of structure driving function. In particular, there has been intense recent interest in the functional role that lipids might play in the plasma membrane. Because of the large number of disease-related molecular processes that take place there, the plasma membrane is a particularly important target of basic research for human health. The plasma membrane is the point at which cell signaling is initiated; it is where drugs, metabolites, and ions enter the cytoplasm from extracellular space; it is the site at which viruses attach to and infect cells, as well as the location of viral particle budding; and it plays a central role in determining and maintaining cell morphology. Synthetic lipid bilayers have been essential tools for elucidating the supermolecular structure of the plasma membrane and investigating membrane proteins. Such synthetic systems are an obvious platform on which to perform fundamental studies of lipid function. Here, we propose to deploy a new class of synthetic lipid bilayers to begin drawing connections between the structure of lipid molecules-both in terms of individual molecular structure and supermolecular organization-and the function of the plasma membrane. These synthetic bilayers, called asymmetric giant unilamellar vesicles (AGUVs), are designed to uniquely mimic the cell membrane, capturing properties such as compositional asymmetry, molecular crowding, and cell geometry better than other existing synthetic lipid bilayers. Specific Aim 1: Validate the biological relevance of asymmetric giant unilamellar vesicles (AGUVs) formed by microfluidic layer-by-layer assembly. We have confirmed our capacity to form asymmetric giant vesicles with differential fluorescence quenching experiments. We will confirm that these structures behave like cell membranes by demonstrating annexin V binding to phosphatidylserine in the AGUV membrane and monitoring lipid diffusive properties. Specific Aim 2: Evaluate how membrane composition affects the dynamics of the passive transport of small molecules into cells. Passive transport through the plasma membrane is an important route for drug delivery and passage of environmental toxins into cells. Recent results show that the mechanism of this transport is complex, and highly dependant on lipid behavior. We will develop a unique AGUV-based technique for systematically measuring the dynamics of solute molecules interacting with and penetrating lipid bilayers, yielding richer mechanistic data than other approaches are capable of delivering. Specific Aim 3: Probe the effects of compositional asymmetry on the mechanics of the plasma membrane. The mechanical properties of the plasma membrane-particularly resistance to bending-help control protein function and are important in a range of physiological processes in which high-curvature cellular structures are formed, such as vesicular budding and the formation of primary cilia in development. While synthetic lipid bilayers have been used to probe these properties, little is known about the effects of bilayer asymmetry (particularly charge asymmetry) on them. AGUVs facilitate straightforward tests of the relationship between bilayer composition and mechanical properties. Specific Aim 4: Develop new tools for probing interactions between lipids and membrane proteins in AGUVs. Lipid interactions with integral membrane proteins are likely a major mode by which lipids influence cell behavior. Very little is known, however, about the origins or controlling parameters of these interactions. We will begin to untangle this problem in AGUVs by using fluorescence microscopy to probe how peptides modeling the transmembrane regions of various proteins associate with segregated lipid domains. Specific Aim 5: Investigate the effects of cytoplasmic molecular crowding on the processes studied in Aims 2-4. Macromolecular crowding-the standard state in the cytoplasm-has profound effects on the chemical behavior at interfaces such as the cell membrane. Using a model of crowding made uniquely possible by our microfluidic technique for forming AGUVs, we will investigate how crowding alters passive transport across the membrane, membrane mechanics, and lipid-protein interactions.